Admin Core

Project Summary/Abstract:
The Administrative Core will oversee operations of the Mayo Clinic P20 Center “Renal macrophages in the
pathogenesis of human urinary stones and Randall’s plaque formation in mice” and serve as the
interface between diverse Center activities and CAIRIBU, the Urology Centers Program, NIDDK, the Mayo
Clinic administrative structure, and the Urology Research Community. The Administrative Core will also
interact with an External Advisory Committee, whose members’ expertise will complement the Center
administrative and programmatic leadership. The Administrative Core will be responsible for executing the
Center’s communication plan, thereby disseminating our ongoing research findings and resources for urinary
stone research to the urology research community. The Core will also coordinate interactions with CAIRIBU
and the Urology Centers Program via the bimonthly Center Leaders meetings, CAIRIBU annual meeting, and
CIRIBU Interactions Core. To further catalyze USD research, the Administrative Core will oversee the Center’s
Education Enrichment Programs. The Core will identify potential collaborators. Key components of the
Educational Enrichment Program include ongoing seminar series with Urology, Nephrology and
Physiology/Biomedical Engineering at Mayo, as well as an annual kidney stone retreat hosted at Mayo Clinic.
Over the last 12 years, the Mayo Clinic has also actively engaged 47 bright young students in our Kidney
Stone research programs via our nephrology/urology summer undergraduate research fellowship (nuSURF)
program. Moreover, Mayo Clinic offers opportunities to encourage research through an endourology fellowship
program designed to promote academic urologists and future leaders in the field.
aken together, the Specific Aims of the Administrative Core are to:
AIM 1: Ensure adherence to the overall goals of the P20 Center and NIDDK Urology Center’s Program.
AIM 2: Coordinate, manage, and integrate the P20 Center’s components and activities, which includes
coordinating ongoing research.
AIM 3: Coordinate and oversee a vibrant Educational Enrichment Program to promote interest in urinary stone
disease research.
AIM 4: Serve as a resource to the wider urologic research community by harmonizing with CAIRIBU and other
Urology Centers Programs and research networks.